EVALUATION OF LIVE ROTAVIRUS VACCINES

In order to protect against the four epidemiologically important rotavirus serotypes, we developed a rotavirus vaccine that contains four distinct strains: rhesus rotavirus (RRV) representing serotype 3 (the Jennerian approach), and three human RV-RRV reassortants, each possessing ten RRV genes and a single human RV gene that encodes VP7 (a major outer shell protein) that is responsible for serotype 1, 2, or 4 specificity (the modified Jennerian approach). Efficacy trials of this orally delivered vaccine have been completed in over 10,000 infants and young children with single or multiple vaccine components with successful results in most but not all studies. In five of these trials which included over 7000 infants and young children, the quadrivalent formulation, given orally in three doses, has been shown to be effective: protective efficacy against severe rotavirus diarrhea ranged from 69% to 91% in various locations. The vaccine was 75% to 100% effective in preventing dehydrating diarrheal illnesses. Because of the demonstrated safety (transient fever) and efficacy of the quadrivalent vaccine, on January 31, 1997 Wyeth Laboratories, the licensee, submitted a Product License Application to the Food and Drug Administration (FDA) and on December 12, 1997, the FDA Advisory Committee concluded that the clinical data presented supported the safety and efficacy of the quadrivalent rotavirus vaccine. On February 11, 1998, and again on June 25, 1998, the Advisory Committee on Immunization Practices recommended its use for infants at ages 2, 4, and 6 months of age. Subsequently, on August 31, 1998 the FDA granted a Biologics License to Wyeth Laboratories. and on November 4, 1998, the American Academy of Pediatrics recommended the rotavirus (Rv) vaccine. In addition, on May 7, 1999, the European Commission issued marketing authorization for the Rotavirus Vaccine with this approval covering all 15 member countries of the European Community.In related continuing rotavirus vaccine studies, we are evaluating collaboratively the feasibility of administering the licensed vaccine to neonates to determine its reactogenicity and immunogenicity with different administration schedules. This study will not only provide information on the immunogenicity of the vaccine when the initial dose is given during the neonatal period, but is also designed to compare the immunogenicity of a two-dose vs a three-dose schedule administered at 2 and 4 months and at 2, 4, and 6 months, respectively, the latter the currently approved schedule. We are also evaluating collaboratively several second generation vaccines. One of these, is a quadrivalent reassortant rotavirus vaccine that possesses a single VP7 gene with serotype 1, 2, 3, or 4 specificity and the remaining ten genes from bovine RV (UK). - Human Subjects